Novel Approaches for Identification of Idiopathic Pulmonary Fibrosis Therapy Targets Using Microscale Collagen Hydrogels

Project Summary/Abstract
Idiopathic pulmonary fibrosis (IPF) impairs respiration through scarring of the interstitial space, resulting in (1) a
stiffened lung that prevents inhalation and (2) limited gas exchange to adjacent pulmonary vasculature. Patients
rely on lung transplants to extend their life beyond the median 3-year survival post-diagnosis as the only
therapeutic agents used for IPF treatment slow disease progression are unable to cease or reverse fibrosis. The
deficiency of pharmaceutical treatment strategies coupled with poor lung transplant survival rates indicates an
obvious need for development of effective treatment options. Unfortunately, drug discovery has largely been
restricted by physiologically irrelevant animal models and by reagent exhaustive, minimally informative in vitro
platforms. The main goal of this proposal is to demonstrate our ability to identify pathways of importance in
fibrotic progression and, by probing the IPF disease space, ultimately aid in therapeutic development. The
outlined methodology enables biological discovery by systematically probing heterogenous populations of IPF
cells by investigating functional behaviors of fibrotic cells from two complementary approaches.
The first proposed methodology stratifies cell populations prior to encapsulation in collagen hydrogels to enable
studies on how specific surface markers effect fibrotic behavior. Using flow sorting techniques, primary
fibroblasts derived from IPF patients are separated into high and low expressing populations of specific surface
receptors, a method that enhances the rarity and value of these precious cells. Stratified fibroblasts are then
encapsulated in miniature collagen hydrogels using reagent-efficient microfluidic devices, reducing total cell
volumes required for each condition and maximizing the number of surface receptors that can be investigated
from a given cell source. Effects of low and high receptor expression will then be quantified and compared using
several metrics of fibrotic function previously optimized. The second approach identifies potential therapeutic
targets by functionally sorting and sequencing single fibrotic cells based on their contractility. Single fibroblasts
are encapsulated into the previously described microgels and cultured to allow for spreading, adhering, and
contracting of the cells into the surrounding matrix. As the cells exert force on the nearby collagen fibers, they
compact the gel into a smaller sphere. Due to heterogeneity in the contraction ability of these fibroblasts,
constructs are greatly varied in size and size-based sorting mechanisms are employed to segregate the most
and least contractile cells. RNA sequencing is then used to directly compare transcriptomic profiles to fibroblast
contractility and to identify upregulated pathways of interest. To validate sequencing hits as important
mechanisms driving fibrotic functions, function-blocking antibodies and pharmaceutical inhibitors are used to
confirm loss in fibrotic function for fibrogenic subpopulations.

Public health relevance
PROJECT NARRATIVE In the following proposal we outline the development of methodology that will reveal functional pathways involved in idiopathic pulmonary fibrosis (IPF), a debilitating and incurable lung fibrosis in drastic need of improved strategies for drug discovery. Through completion of the proposed aims, our novel in vitro system will identify possible therapeutic targets for IPF through both specific identification of pathways involved in cell surface signaling as well as open-ended transcriptome sequencing. The ability to probe discrete cells and link fibrotic behaviors of contractility directly to molecular processes makes this an invaluable and novel platform for studying IPF.